Consolidation and interference of hippocampal spatial maps

Project Summary
Neurons throughout the brain remain highly active during sleep and produce complex patterns of action
potentials. In unit recordings from the hippocampus, by comparing these patterns against earlier behavioral
templates, numerous groups have shown that during hippocampal sharp-wave ripple (SWR) events these
sleep patterns can correspond to replays of earlier experience. Additional research has further indicated that
these SWR patterns play an important role in long term retention of memory. Developing and using advanced
machine learning techniques and large-scale population recordings, we have recently demonstrated two
remarkable phenomena during SWRs: that individual SWR-associated replays correspond to memories of
specific individual experiences within a context, and that the fine scale representations of individual neurons
can be detected and dynamically tracked across SWRs. Including our own studies, the study of SWRs has
largely focused on the relationship between sleep and experiences within individual contexts. However,
numerous experiments report that sleep and the hippocampus are also critically involved in isolating memories
of experiences in distinct contexts, a process which fails in the case of interference. In this proposal, we
describe a series of experiments which will allow us to test the hypothesis that hippocampal ensemble activity
during sleep SWR can either support the stabilization of the memories of experiences within different contexts
or mechanistically underly the failures of context-specific memory in interference. In Aim 1, we will further
develop our machine learning techniques for studying the evolution of hippocampal codes during sleep SWRs
– providing new approaches to quantifying the tuning and retuning of single neurons following specific
experiences and measuring the interactions of context-specific manifolds within SWRs. In Aim 2, we will carry
out the key experiments in different behavioral paradigms designed to optimize for ensemble manifold
detection, isolation of individual behavioral experiments, and context-specific behavior. Finally, in Aim 3, we will
implement closed-loop signal processing to test the necessity of sleep SWRs for the expression of context-
specific memories. Collectively, our proposed work will provide a critical foundation to understanding how
hippocampal activity during sleep underlies our properly functioning memories.

Public health relevance
Project Narrative Our research indicates neurons in the brain, particularly within the hippocampus, remain active during sleep, replaying patterns that correspond to previous experiences and contributing to the long-term retention of memories. We aim to advance our machine learning tools to dissect how these sleep patterns, known as sharp-wave ripples, contribute to stabilizing memories within different contexts and study the mechanistic role they play when memory interference occurs. Through a series of experiments, we will analyze the encoding of experiences by neuronal ensembles during sleep, investigate how sharp-wave ripples aid in segregating contextual memories, and test if these patterns are crucial for recalling context-specific information, ultimately enhancing our understanding of memory function.